DP22-002 Epidemiology of Lupus: Longitudinal Studies in Population-Based Cohorts - 2022

PROJECT SUMMARY
Systemic Lupus Erythematosus is a systemic autoimmune condition which is life long and can be life threatening.
Up to 15-20% of all SLE patients are diagnosed in childhood (<18 years of age). Although it is estimated that up
to 10,000 children in the United States have pediatric-onset SLE (pSLE), the natural history, treatment and
outcomes for this vulnerable population of children have not been well defined.
We propose to use the well-established Childhood Arthritis and Rheumatology Research Alliance (CARRA)
pSLE registry, which currently includes 870 patients followed longitudinally for up to ten years (goal of enrolling
1300-1400 participants), in order to thoroughly assess the biologic/disease related factors, as well as the non-
biologic factors, which can impact short and long-term pSLE outcomes. This proposal will address critical gaps
in pSLE knowledge including description of treatments for lupus nephritis and the prevalence and outcomes of
neuropsychiatric pSLE, the two primary causes of pSLE short and long-term morbidity. In addition, we will
describe important patient reported outcomes including pain, quality of life and disability, and long-term
outcomes, including transition to adulthood.
Research findings will be disseminated through patient/family partnerships with a goal of developing future
interventions to improve the health and well- being of patients with pSLE.

Public health relevance
PROJECTIVE NARRATIVE Systemic Lupus Erythematosus is a life long autoimmune condition which can be life-threatening. Up to 20% of all Lupus patients are children diagnosed prior to 18 years of age. This study will utilize a large cohort of pediatric Lupus patients in a long-term United States registry to understand the disease, best treatments and what factors influences important outcomes important to both patients and providers.